A novel more effective genotoxic therapy for ovarian cancer

PROJECT SUMMARY
High-grade serous ovarian cancer (HGSOC) is the most lethal gynecological malignancy. More than 80% of
HGSOC patients recur after frontline standard therapy, and complete and durable responses are rare. Therapies
that improve compete tumor regression and prevent relapse are needed. Our GOALS are to i) identify which
ovarian cancer genetic subsets will benefit from a new more effective genetically targeted therapy using primary
tumor cultures, patient-derived xenograft models and human tumor samples from our clinical trial, ii) identify
mechanisms of acquired resistance with genetic validation.
We have identified a novel and highly active genotoxic therapy by co-inhibiting poly-ADP ribose polymerase
(PARP) and ATR checkpoint kinase. Combination PARP inhibition with ATR inhibition (PARPi-ATRi) synergizes
to specifically target and kill HGSOCs harboring common HGSOC-associated alterations, e.g. homologous
recombination (HR) deficiency and Cyclin E overexpression. Our preliminary studies show that PARPi-ATRi in
combination is especially effective in killing HGSOC cells with these alterations and causes regression of HR-
deficient and Cyclin E overexpressing HGSOC patient-derived xenografts (PDXs). These results have stimulated
a clinical trial of PARPi-ATRi combination in recurrent HGSOC (unselected patient population) to be led by the
PI of this proposal. This will be the first trial evaluating PAPRi-ATRi combination in ovarian cancer.
Here, we propose to validate in vitro findings and expand the use of our PDX model, a reliable HGSOC
surrogate, to test the effectiveness of this novel PARPi-ATRi combination in killing HGSOCs that either
overexpress Cyclin E-or have acquired PARPi-resistance, which together cause most deaths from HGSOC. Our
clinical trial of PARPi-ATRi for treatment of recurrent HGSOC will be performed in parallel with the expanded
preclinical mouse studies. This will allow us to correlate predictive biomarkers (HR-deficiency and Cyclin E
overexpression) of response and potential resistance mechanisms (e.g., BRCA reversion mutations).
This PARPi-ATRi combination therapy is promising; however, this treatment causes tumor regression initially
in chemo-resistant Cyclin E-overexpressing tumors but acquired resistance ultimately develops. Using genomic
and proteomics, we will integrate alterations discovered in the PAPRi-ATRi-resistant and sensitive PDXs with
patient samples from the clinical trial to develop a candidate pool list. Candidate genes associated with resistance
will be refined by prioritizing alterations found at both the gene and protein level and that are druggable. The top
candidates will be validated in vitro using a targeted CRISPR knock-down approach. Defining markers of
response and resistance will help stratify patient populations, optimize treatment strategies and identify new
targets for future therapeutics based on HGSOC cancer genetics.

Public health relevance
NARRATIVE A novel combination therapy that targets common genetic alterations in ovarian cancer will be tested for efficacy in promoting tumor regression and preventing relapse in ovarian cancer. Proposed studies will use novel patient-derived xenograft models and tumor samples from patients in the first clinical trial in ovarian cancer testing this therapy.